EVALUATION OF ACUTE AND CHRONIC EFFECTS OF ANTIARRHYTHMICS IN MAN

Proposed research will test in man hypotheses founded in basic research which have the potential for improvement of therapy of ventricular arrhythmias.